CHEMOSENSORY PROCESSING IN THE NERVOUS SYSTEM

The mechanisms by which animals and humans process the chemical sensory information that permit them to smell and taste are not understood. This problem will be investigated using the leech, a powerful model system in which, to a much greater extent than in higher animals, the cells of the nervous system can be studied directly and individually. The elements of the leech chemosensory system(s)-including the peripheral chemoreceptors, the nerves leading from them to the central nervous system, and the neurons in the central nervous system that are involved in chemosensory processing-will be identified and characterized using the methods of extracellular and intracellular electrophysiological recording, light and electron microscopy, and metabolic mapping of active neurons with 3H-2-deoxyglucose. Induced in the characterization of these elements will be a description of the way they interact with each other to allow discrimination of different chemical stimuli. This work has two long range goals: 1) to discover how chemical sensory information is processed by the nervous systems of animals, including humans, and 2) to further characterize the nervous system of the leech, a valuable model system in neurobiological research, and one in which new methods and principles have repeatedly been developed and later applied to the study of higher animals.